2025 Collagen Gordon Research Conference and Gordon Research Seminar

Collagens are superfamily of extracellular matrix proteins that are fundamental, but poorly understood,
constituent of all tissues and organs throughout the animal kingdom. Cells that produce and deposit collagens
have developed specialized adaptations for collagen biosynthesis and there are classes of enzymes that are
dedicated to post-translationally modifying collagens. Mutations in collagens or collagen-modifying enzymes
cause a broad range of human disorders affecting any organ. Given the significant role of collagens and collagen-related proteins to all manner of heath and disease, it is important that we fill knowledge gaps of how collagens
regulated, what are their primary functions, and how different biochemical or biophysical states alter these
functions.
The 2025 meeting will build on rich tradition of continuous meetings since 1970, interrupted only by the global
pandemic that caused postponement of the 2021 meeting. During this time, the Collagen GRC has become the
preeminent international conference on the study of collagens. In conjunction with this, 2013 witnessed
establishment of the associated Gordon Research Seminar (GRS) that has a specific focus on early career
researchers. There are two main goals of the 2025 GRC/GRS are: 1) to share innovative and unpublished studies
spanning the breadth of collagen research from biochemical and biophysical properties to understanding and
treating collagen-related genetic disease; 2) to foster and empower the next generation of leaders in the field.
We will accomplish these goals with a program that features (i) a plenary session that comprised of two early
career researchers, (ii) two sessions on collagen biosynthesis, (iii) two sessions on collagen and collagen-related
diseases, (iv) two sessions on collagen chemistry and biophysics, (v) one session on advanced imaging and
model organisms, and (vi) a forward-looking session on big data and computational approaches. The program
was designed to emphasize the role of early career researchers and with attention to a range of career stages
and international interaction. The program represents invited speakers from 15 countries.
The conference is held on the campus of Colby Sawyer College in New London, NH which fosters interaction
among meeting attendees. The conference begins with an evening plenary session followed by four full days of
invited and selected speakers. Each day also has a poster session and dedicated time for networking and social
interactions. One afternoon has been set aside for the GRC Power Hour that is designed to address best
practices in the scientific workplace by providing a conversation amongst colleagues of all career stages. The
program supports the professional growth of all members of our communities by providing an open forum for
discussion and mentoring.

Public health relevance
PROJECT NARRATIVE Collagens are the most abundant proteins in the human body where they provide tissues with structure and serve as solid state signaling platforms. They are fundamental components of all tissues and organs and impact numerous facets of health and disease. The 2025 Collagen Gordon Research Conference and accompanying Gordon Research Seminar will facilitate exchange of information, data, and cutting-edge techniques while enabling fostering growth for the next generation of collagen researchers.